Dissecting Persistent Cell Populations in Rhabdomyoscaroma

PROJECT SUMMARY
Children with unresectable or metastatic solid tumors have continued to have poor outcomes and high
recurrence rates. For example, in pediatric rhabdomyosarcoma (RMS), the most common childhood soft tissue
sarcoma, 70% of patients with metastatic disease experience disease recurrence; after recurrence, 5-year
overall survival drops below 20%. In previously published work, Dr. Patel generated a single-nucleus RNA-
sequencing atlas of RMS to better clarify the diversity of malignant cell states within both fusion-negative RMS
(FN-RMS) and fusion-positive RMS (FP-RMS). RMS tumors recapitulate the hierarchy of muscle cell states
within normal embryogenesis. In FN-RMS, rare tumor cells that expressed genes reminiscent of paraxial
mesoderm progenitors survive therapy, and these progenitor-like cells are sufficient to propagate FN-RMS
tumors in xenografts. As such, progenitor-like cells represent a critical reservoir of therapy-tolerant cells within
FN-RMS. Based off these findings, Dr. Patel will combine computational and experimental biology tools to
investigate how cell state hierarchy is maintained within FN-RMS. In Aim 1, Dr. Patel will receive training in the
application of systems biology computational algorithms to single-cell RNA-sequencing data and in chromatin
profiling to dissect the transcriptional and epigenetic determinants of FN-RMS progenitor-like cell identity. In Aim
2, Dr. Patel will receive training in flow cytometric cell sorting and spatial proteomics to test whether progenitor-
like cells undergo feedback control and interact with non-malignant cells of the tumor microenvironment. To
support and mentor Dr. Patel, he has developed a career development plan that will be overseen by a diverse
mentorship team including: his mentor, Dr. Michael Dyer, a distinguished developmental biologist with a long
track record of developing patient-derived models of pediatric cancers, and advisors with expertise in
epigenomics (Dr. Stephen Mack), systems biology (Dr. Jiyang Yu), clinical sarcoma treatment (Dr. Alberto
Pappo), treatment persistence (Dr. Doug Green) and tumor-immune interactions (Dr. Paul Thomas). Additional
collaboration from Dr. Jasmine Plummer and the St. Jude Center for Spatial Omics will provide technical support
and guidance. This proposal will support Dr. Patel in the transition from mentored research to an independent
career as a physician-scientist and will generate preliminary data to support a competitive R01 submission. By
completing the plan outlined in this proposal, Dr. Patel will be poised to lead an impactful research program
focused on overcoming the challenge of recurrence and drug persistence in pediatric solid tumors.

Public health relevance
PROJECT NARRATIVE Children with rhabdomyosarcoma (RMS), the most common soft tissue sarcoma of childhood, suffer poor outcomes due to high rates of recurrence. In this proposal, I will leverage experimental models of fusion- negative to pinpoint the molecular control mechanisms governing intratumoral heterogeneity and cell state identity in fusion-negative RMS. The results from this proposal will identify biomarkers of treatment efficacy, and will build a foundation for future treatment options for RMS.